Epigenetic alterations after DNA damage repair drive treatment resistance in glioblastoma

PROJECT SUMMARY/ABSTRACT
In this K08 career development award, the principal investigator (PI) aims to determine how DNA-methylation is
altered after DNA damage and investigate the impact of these changes on 3D chromatin organization, gene
regulation and treatment resistance. The PI studies this process in glioblastoma, a difficult to treat malignant
brain tumor. Training and mentoring activities will facilitate meeting not only scientific goals, but also the principal
investigator's career development by addressing gaps in knowledge and expanding training through coursework,
meetings, networking, and an expert mentoring team consisting of a primary mentor, co-mentor, and four faculty
advisors. The research proposed will be addressed through this K08 phase of training and serve as the scientific
basis for the applicant's career as an independent investigator. The candidate will acquire skills necessary to
complete the aims through selected mentors with non-overlapping expertise and coursework. The central
hypothesis is that, after DNA damage repair, the local epigenetic state is not restored correctly, leading to
epigenetic alterations, gene expression changes and treatment resistance. This hypothesis is tested using
human patient-derived glioblastoma cell cultures as a model system. The rationale for this project is the
observation that stochastic DNA methylation alterations can be detected with radiation damage models, and
endonuclease damage can alter local DNA methylation states. The mechanism underlying this process and the
extent to which it occurs in cancer, however, is not known. This hypothesis is challenging to test using stochastic
damage, such as radiation, or traditional endonuclease damage models, which are unable to cut methylated
DNA, and have a fixed and limited number of sites. To circumvent this issue, the investigator developed a
CRISRP-Cas9 tool to reproducibly induce genome-wide double strand breaks to study DNA methylation
alterations and genome organization around sites of DNA damage. The central hypothesis will be tested by two
specific aims to (i) test how DNA methylation and genome organizational alterations evolve at damaged DNA
loci, and (ii) test if genome re-organization factors can be targeted therapeutically during radiation stress. This
training proposal is innovative because it (i) develops tools to map DNA methylation and 3D chromatin
organization alterations following DNA damage and (ii) implicates this process in treatment resistance. The
significance of this proposed research is that it fills knowledge gaps in epigenetics, DNA-damage repair, and the
understanding of the effects of treatment on cancer cells. Successful completion of these studies will provide
translatable insight into the interplay between DNA damage, DNA methylation and genome re-organization in
glioblastoma.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to public health because it addresses a fundamental gap in understanding how DNA damaging therapies such as radiotherapy and chemotherapy lead to epigenetic alterations and treatment resistance in cancer. Addressing this knowledge gap and developing strategies to study this process will open new therapeutic avenues for cancer treatment. Therefore, the proposed research is relevant to the NIH's mission of seeking fundamental knowledge that can lengthen life and reduce illness.